Susceptibility determinants to Legionella pneumophila infection in smokers

Susceptibility determinants to Legionella pneumophila infection in smokers
Abstract
Legionella accounts for majority of drinking water-associated pneumonia outbreaks with high percentage of
death. Legionella infection presents with a higher risk and worse outcome in the elderly, immune-compromised
and smokers. Several epidemiological studies have demonstrated a strong association between tobacco
smoking and an elevated risk of Legionella infection. However, the underlying mechanism is still unclear. To
determine the mechanism by which smoking predisposes to Legionella infection, we will perform the following
aims:
Aim 1. Determine the methylomic and RNAseq profile of human alveolar macrophages from current smokers
(>10 pack years) and non-smokers. Aim 2. Determine the function of genes with altered methylation and
expression and identify those responsible for the increased susceptibility of macrophages to Legionella
infection.

Public health relevance
Project Narrative Legionella tend to infect the elderly, people with low immunity and smokers causing pneumonia that is often fatal. In order to understand why smokers are prone to Legionella infection, we will obtain macrophages from the lungs of smokers and determine if they express genes different than those from non-smokers.